NCATS CHALLENGE AWARD - INITIAL OBLIGATION - LITCOIN NLP CHALLENGE

With an ever-growing number of scientific studies in various subject domains, there is a vast landscape of biomedical information which is not easily accessible in open data repositories to the public. Open scientific data repositories are either incomplete or too vast to be explored to their potential without a consolidated linkage map that relates all scientific discoveries. This massive amount of medical knowledge can be computationally transformed into knowledge graphs that can be used in an open data repository and has the potential to assist in identifying gaps in medical research and accelerating research for unexplored medical domains through scientific investigations. However, open medical data on its own is not enough to deliver its full potential for public health. Engaging technologists, members of the scientific and medical community and the public in creating tools with open data repositories, funders can exponentially increase that data’s utility and value to help solve pressing national health issues. The LitCoin Natural Language Processing (NLP) Challenge seeks to spur innovation by rewarding the most creative and high impact uses of biomedical publication free text to create knowledge graphs that can link concepts within existing research, to allow researchers to find connections that may have been difficult to discover without them.